Intervention to Enhance Lateral Balance Function and Prevent Falls in Aging

DESCRIPTION (provided by applicant): Falls and their consequences are among the major problems in the medical care of older individuals. The long-term goal of this research is to establish the efficacy of a scientifically grounded and mechanism-based therapeutic intervention for improving balance function and preventing falls in older people. When human balance is challenged, protective stepping is a vital strategy for preventing a fall during activities of daily life. Many older people at risk for falls have particular difficulties with successfully stepping sideways as a protective response to loss of balance in the lateral direction. We propose that age-related declines in lateral balance function through impaired protective stepping that precipitates falls, result from neuromechanical (NM) limitations in hip abductor-adductor (AB-AD) muscle strength (torque and power). Moreover, we hypothesize that these functional and NM impairments are reversible with combined, high intensity induced, step training and muscle strengthening. The specific aims are to conduct a double blind, randomized, and controlled trial with four training arms that will compare the effects of 12 weeks of training and assess its durability after 3 months of no training in community living older adults at risk for falls by determining: 1) the effect of (a) waist-pull induced step training, (b) hip AB-AD muscle strengthening, and (c) a combined step training and muscle strengthening program compared to (d) a standard flexibility and relaxation program involving minimal-intensity exercises (control) on the protective stepping response to an external balance perturbation, as measured by i) the number of multiple balance recovery steps, and ii) first step length; and 2) the effect of high intensity step training, with and without the strengthening intervention, compared to the control group on a) maximum hip AB- AD joint torque and power. A secondary aim will assess whether protective stepping performance and hip AB- AD muscle strength discriminate between a) fallers and non-fallers identified by retrospective fall history at the time of study enrollment, and b) the prospective fall frequency of the different intervention groups during 1-year follow-up post-training.

Public health relevance
PUBLIC HEALTH RELEVANCE: The relevance of this research to public health lies in its focus on understanding the causes of age-associated falls and on the development of effective interventions for minimizing the devastating economic, societal, and personal consequences of falls among older people. Relevance The relevence of this research to public health lies in its focus on understanding the causes of age-associated falls and on the development of effective interventions for minimizing the devastating economic, societal,and personal consequences of falls among older people. __SpecificAimsTextDelimiter__ A. Specific Aims Falls and their consequences are among the major problems in the medical care of older individuals. The long-term goal of this research is to establish the effectiveness of a scientifically grounded and mechanism based therapeutic intervention for improving balance function and preventing falls in older people. The ability to increase the body's base of support by stepping is a crucial protective response to stabilize standing balance and prevent falling. We have previously demonstrated that successfully stepping sideways as a protective response to imbalance is problematic for many older individuals. Lateral stepping responses are normally dependent upon high force, high speed usage of hip abductor-adductor (AB-AD) muscles to effectively move the limbs in the medio-lateral (M-L) direction with the correct timing and distance in order to prevent a fall from occurring. In older adults, difficulties with protective stepping are characterized by the frequent use of multiple short recovery steps with dangerous collisions between the limbs when crossing one limb in front of the other to secure lateral balance. We found that M-L stepping patterns and hip AB strength (joint torque) discriminate prospectively between fallers and non-fallers confirming that these inappropriate balance responses are even more common among older people who fall. Accordingly, we hypothesize that these detrimental changes in lateral stepping patterns result from neuromechanical (NM) impairments in hip AB-AD joint moments of force (torques) that normally regulate lateral balance stability during standing, stepping, and walking. The goal of this study is to show that these impaired lateral balance factors are reversible with high intensity induced step training and muscle strengthening. Previous randomized controlled studies that examined the effects of exercise on fall rates among older adults show that the greatest relative effects are found for programs that included a high level of challenge to balance, and that muscle strength training does not consistently reduce the incidence of falls. However, these studies focused on muscle strengthening have invariably involved the leg flexor and extensor muscles mainly implicated in anterior-posterior balance control, and not those muscle groups more directly involved with lateral balance. Furthermore, isolated muscle and joint strength training without functional muscle and joint use in challenging balance-related contexts employed in previous studies is limited because it ignores important task specificity of exercise training principles. In the current project, we will show that a combined step training and hip muscle strengthening intervention is more effective than 1) high intensity step training, 2) hip AB-AD muscle strengthening, and 3) a standard flexibility and relaxation program involving minimal-intensity exercises (control). By inducing repetitive, high force, high speed use of the intralimb and interlimb hip AB-AD muscles to control lateral stepping responses, we will progressively challenge these key postural muscles in a functionally relevant context that is critical to preventing a fall. The inclusion of a progressive resistance training arm to improve M-L hip muscle torque and power, will permit the direct comparison of the effectiveness of high intensity balance training versus isolated muscle and joint training and their potential synergistic effects as fall prevention strategies. The specific aims are to conduct a double blind, randomized, and controlled trial with four training arms that will compare the effects of 12 weeks of training and assess its durability after 3 months of no training in community living older adults at risk for falls by determining: 1. The effect of (a) step training, (b) hip AB-AD muscle strengthening, and (c) a combined step training and muscle strengthening program compared to (d) a standard flexibility and relaxation program involving minimal-intensity exercises (control) on the response to an external balance perturbation as measured by a) the number of multiple balance recovery steps, and b) first step length. H.1. Compared with the control group, a) all three training groups will demonstrate greater improvements in balance function and hip muscle strength, b) the combined high intensity step training and hip AB-AD muscle strengthening intervention group will demonstrate the greatest improvements in outcomes, and c) improvements in stepping performance and hip strength due to step training and/or muscle strengthening will be maintained at 3-month follow-up compared to the standard flexibility and relaxation exercise training. 2. The effect of step training, with and without the strengthening intervention, compared to the control group on maximum hip AB-AD joint torque and power. H.2. The combined intervention of step training and hip muscle strengthening, and each intervention alone, will improve muscle strength compared to the control group but the combined intervention will achieve the greatest improvements. To translate these findings into community outcomes, a secondary aim will assess a) whether protective stepping performance and hip AB-AD muscle strength discriminate between a) fallers and non-fallers identified by retrospective fall history at the time of study enrollment, and b) the prospective fall frequency of the different intervention groups during 1-year of monthly follow-up post-training. Figure 1 summarizes the theoretical and conceptual framework for the proposed studies. AGING Activity Patterns Limit Functional Use of Hip AB-AD Muscles Ineffective M-L Protective Stepping Decline in AB-AD Muscle Function: ¿ NM Torque/Power Falls & Injuries Lateral Instability Step Training Hip AB-AD M-L Step Training & Hip Muscle Muscle Strengthening Strengthening ¿ Hip AB-AD Muscle Torque/Power ¿ M-L Protective Stepping ¿ Falls & Injuries Figure 1. Summary Conceptual Model that links age-associated limitations in hip abductor- adductor (AB-AD) muscle use due to changes in functional activity patterns that normally more intensively challenge these muscle groups (e.g. single leg weight bearing tasks and moving sideways). These age-associate declines in neuromechanical (NM) function and progressive deconditioning impair lateral balance function during medio-lateral (M-L) protective stepping and other ambulatory situations. The constellation of age-associated changes in physiological and biomechanical function affecting lateral balance stability, increases the risk of falls and their consequences, particularly, hip fracture. Interventional training programs that combine high intensity step training and hip AB-AD muscle strengthening will enhance lateral balance function and reduce the risk of falling.